EFFECT OF KETOGENIC VERY LOW CALORIC DIET ON GLYCEMIA IN NIDDM

Specific aims are to assess the role of ketosis in reducing glycemia during VLCD treatment of obese NIDDM and to determine the efficacy of a more ketogenic VLCD to achieve greater and more rapid glycemic control in obese NIDDM.